Applying a Targeted Machine Learning and Causal Inference Approach to Analyzing Long-Term Sequelae of COVID-19 Infection Through the National COVID Cohort Collaborative.

PROJECT SUMMARY / ABSTRACT
Candidate: I am an epidemiologist in the Division of Biostatistics at the University of California, Berkeley
School of Public Health, and I completed my Ph.D. in Epidemiology in August 2022 at UC Berkeley. Since my
graduation, I have worked with the Center for Targeted Machine Learning and Causal Inference (CTML) to
apply cutting-edge biostatistical and causal inference methods to pressing COVID-19 research questions using
data from the National COVID Cohort Collaborative (N3C). I led a group of CTML epidemiologists and
biostatisticians in the NIH Long COVID Computational Challenge (L3C) competition, where we were honored
with third place for our ensemble machine learning model that accurately predicted the risk of Long COVID
diagnosis based on individual electronic health record (EHR) data in N3C. I aim to become a leader in the
application of innovative biostatistical, causal inference, and machine learning methods to impactful research
questions related to infectious disease epidemiology.
Environment: In order to attain my career goals, my training and mentorship plan will focus on recent
advances in biostatistics, causal inference, and data science methods (Targeted Machine Learning) as well as
immunology and infectious disease epidemiology. I have assembled an interdisciplinary team of expert
biostatisticians, epidemiologists, and clinicians who will support my training. Alan Hubbard (primary mentor)
and Mark van der Laan (co-mentor) will provide expert guidance and mentorship on biostatistics, data science,
and causal inference. Rena Patel (co-mentor) and Jack Colford (scientific advisor) will provide mentorship and
guidance in infectious disease epidemiology and immunology.
Research: Researchers and clinicians have made enormous progress in understanding, preventing, and
treating acute COVID-19 infection, but there is considerable uncertainty regarding the factors associated with
long-term sequelae of COVID-19 infection. Although vaccination is a key strategy for COVID-19 epidemic
control, little is known regarding the role of COVID-19 vaccination timing relative to COVID-19 infection (i.e.,
up-to-date vaccinations and boosters) in preventing long-term sequelae of infection, and the lack of objective
Long COVID biomarkers hampers our ability to evaluate, prevent, and treat Long COVID. In Aim 1, I will
evaluate the relationship between vaccination timing and Long COVID diagnosis in order to determine an
optimized vaccination schedule to minimize Long COVID. In Aim 2, I will assess the relationship between
COVID-19 vaccination timing and individual long-term sequelae of COVID-19 infection. In Aim 3, I will assess
mediation of the relationship between acute COVID-19 infection and Long COVID via interleukin 6 (IL-6) to
evaluate a biological mechanism of interest. I will apply Targeted Machine Learning methods to achieve these
aims, which will prepare me for an R01-level application to apply these methods to research questions in
infectious disease epidemiology.

Public health relevance
PROJECT NARRATIVE Long-term sequelae of COVID-19 infection have a staggering burden on public health and the global economy, but investigators have little understanding of the determinants and mechanisms that underlie this phenomenon. We lack a clear understanding of the role of COVID-19 vaccination timing, or the role of immune biomarkers such as interleukin-6 (IL-6), in determining an individual’s risk of long-term consequences from COVID-19 infection. I will apply innovative Targeted Machine Learning and Causal Inference methods in order to identify an optimal COVID-19 vaccination schedule to minimize the long-term consequences of COVID-19 infection as well as identify mechanistic biomarkers that mediate the relationship between acute COVID-19 and Long COVID.